The role of tumor expression of alpha-myosin in immune checkpoint inhibitor-associated myocarditis

PROJECT SUMMARY
Immune checkpoint inhibitors (ICIs) have transformed the landscape of cancer therapy by unleashing
the body's natural defenses to fight against tumors. However, this potent immunotherapeutic approach is not
without its drawbacks, as it can trigger immune-related adverse events (irAEs), including potentially life-
threatening myocarditis. The pathogenesis of ICI-associated myocarditis (ICI-MC) is poorly understood, but
recent evidence from our lab and others suggests a crucial link to α-myosin, a cardiac muscle protein that is
abnormally expressed in some cancer cells. In this proposal, I seek to extensively investigate the role of tumor-
expressed α-myosin in the development of ICI-MC. My proposal is based on the central hypothesis that tumor
expression of α-myosin can activate T cells specific to this antigen, driving an autoimmune response that
culminates in myocarditis. To test this hypothesis, I will conduct a series of experiments involving mouse
models bearing tumors that do or do not have enforced expression of α-myosin. I will compare the rate and
severity of ICI-MC in these mice to that in mice bearing tumors without α-myosin expression. To assess the
potential of using tumor-expressed α-myosin as a biomarker to predict the development of ICI-MC, I will
analyze RNA and protein expression levels of α-myosin in tumor tissues from patients who developed ICI-MC
compared to those who did not. I will further elucidate the mechanism through which the immune system
interacts with tumor cells through innovative in vitro and in vivo approaches. In vitro, I will perform co-culture
assays to establish whether cancer cells expressing α-myosin can effectively present this antigen and activate
T cells. To validate the T cell activating capacity of α-myosin-expressing tumors in vivo, I will infuse
fluorescently labeled T cells expressing T cell receptors specific for α-myosin into mice bearing tumors
expressing this antigen, and track clonal expansion across tissue sites (heart, tumor, peripheral blood, lymph
nodes). My approach is innovative in that it will be the first study to focus on features of tumor biology, such as
expression of α-myosin, that are associated with an increased risk of ICI-MC. The potential impact of this
research is significant. In completing this proposal, I will deliver urgently needed insights into the
pathophysiology of ICI-MC, with the potential to unveil new approaches for screening and prevention of the
disease. If a definitive association between tumor expression of α-myosin and the development of ICI-MC can
be made, this could serve as a much-needed biomarker to identify patients at risk of developing this severe
irAE. It would also provide a foundation for the development of new strategies to prevent irAEs in patients
undergoing ICI therapy. This research could contribute to a broader understanding of the immune response to
cancer therapy, ultimately enhancing the efficacy and safety of ICIs for a wide variety of cancer patients.
Furthermore, the completion of this project will facilitate the development of my technical, critical thinking, and
communication skills that will be crucial to my success as an independent physician-scientist.

Public health relevance
PROJECT NARRATIVE Myocarditis is a severe complication associated with immune checkpoint inhibitors used for cancer immunotherapy, but the mechanisms underlying this disease remain poorly understood. This proposal will determine the role of tumor cell expression of the cardiac antigen α-myosin in the development of immune checkpoint inhibitor-associated myocarditis (ICI-MC). The insights gained will improve our mechanistic understanding of ICI-MC, enabling the development of improved screening and prevention options for patients at high risk for ICI-MC, ultimately improving patient outcomes.